BLRD Research Career Development Transition Award Application

This proposal seeks to support Garth Terry, MD, PhD, a VA psychiatrist, and clinician scientist, during his
Merit Review award and the initial phase of his independent research career. Dr. Terry has over two decades
experience developing radiotracers for use in positron emission tomography (PET), which allows non-invasive
imaging of central nervous system (CNS) activity in living persons. PET imaging has been responsible for
critical breakthroughs in the understanding of many neuropsychiatric disorders and has been employed in the
development of novel drugs for their treatment. Dr. Terry’s training in radiochemistry, preclinical and clinical
research, and his clinical experience as a psychiatrist make him particularly well suited for developing novel
radiotracers for PET imaging of CNS systems implicated in neuropsychiatric disorders affecting Veterans.
Specifically, the goal of this proposal is to provide support and protected time for Dr. Terry to continue
development of a CNS α1 adrenoceptor (α1 AR) PET radiotracer (the Specific Aims of his Merit Review award),
advance that radiotracer to first-in-human imaging studies, expand his successful radiotracer development
pipeline, continue collaborative research projects, and prepare funding applications to maintain his career as a
successful VA investigator. The overall focus of Dr. Terry’s radiotracer development efforts is on imaging CNS
receptors implicated in the pathophysiology of neuropsychiatric disorders common among Veterans, such as
posttraumatic stress disorder (PTSD), mild traumatic brain injury and persistent postconcussive symptoms,
alcohol and cannabis use, and neurodegenerative disorders. CNS adrenergic, endocannabinoid, and
neuroinflammatory systems all mediate stress response, are biologically interconnected in these disorders, and
are clinically accessible by therapeutic medications. Therefore, they constitute targets for the development of
PET radiotracers in his laboratory.
Excessive noradrenergic (NA) activity has been identified as an important contributor to PTSD pathology,
and prazosin, a non-selective α1 AR antagonist, has demonstrated effectiveness in reducing PTSD-related
nightmares, sleep disturbances, and dysregulated alcohol use in Veterans and Servicemembers (SMs).
Unfortunately, for reasons that remain unclear, not all Veterans and SMs tolerate or respond to prazosin
therapy. A major factor impeding research into understanding NA system regulation in PTSD and the variable
therapeutic response to prazosin has been the inability to image α1 ARs in living human brain. Dr. Terry’s
laboratory has developed a carbon-11-labeled PET radiotracer that displays high affinity and selectivity for α1A
ARs and shows promise for CNS PET imaging. However, its widespread use is limited by its short radioactive
half-life (20.3 min). The Merit Review award seeks to mitigate this limitation by developing a fluorine-18 labeled
radiotracer with a longer half-life (109 min) and prepare an exploratory investigational new drug application.
Efforts in this proposal beyond the Merit Review seek to use the α1 AR radiotracer to map α1 AR
distribution and binding affinity in Veterans with versus without PTSD, in an effort to obtain direct in vivo data
supporting or refuting the role of CNS α1 ARs in the pathophysiology of PTSD. Human imaging of brain α1 ARs
will also allow determination of the CNS concentrations of prazosin associated with amelioration of PTSD
symptoms, information that could potentially assist VA clinicians in determining clinically effective doses of
prazosin. As the first radiotracer for imaging CNS α1 ARs in human, the radiotracer can be expected stimulate
collaborative efforts with VA and non-VA researchers, further extending its impact. It also provides proof-of-
concept that Dr. Terry’s PET radiotracer development pipeline can support the development of additional CNS
radiotracers targeting Veteran-relevant neuropsychiatric conditions.
Protected time and support are required to achieve these goals and further their efforts through preparation
of competitive funding applications. Doing so will provide the launch for a successful VA research career.

Public health relevance
Garth Terry, MD, PhD, is a VA psychiatrist and researcher with extensive training and expertise developing new compounds for positron emission tomography (PET) imaging of brain neurotransmitter receptors in living persons. His laboratory seeks to visualize how brain stress response systems contribute to disorders such as posttraumatic stress disorder (PTSD), concussion, drug and alcohol use, and dementia, all of which affect many Veterans. By imaging the actions of drugs targeting the brain noradrenaline system (responsible for fight or flight responses), endocannabinoid system (responsible for the effects of cannabis), and immune system (responsible for brain inflammation) his laboratory hopes to better understand the underlying mechanisms of these disorders and to develop new and better treatments for them. This proposal seeks to support Dr. Terry during his current research project and provide the foundation for his further development as a clinical PET researcher addressing the unmet needs of Veterans affected by neuropsychiatric disorders.